Integrative Prediction of Therapeutic Response in T-cell Lymphoma by Omic and Spatial Modeling

ABSTRACT
The tumor ecosystem plays a critical role in tumor development, progression and therapeutic response.
Previous studies have utilized dissociative and single-cell omics technologies to profile the tumor ecosystem,
specifically to understand therapeutic resistance and identify predictive biomarkers for precision cancer
medicine. Yet, very few of these biomarkers have adequate performance characteristics for adoption in clinical
practice. We hypothesize that a fundamental facet of the tumor ecosystem, i.e., the spatial organization of
cells, which encodes key information involving paracrine and juxtracrine interactions that drive “neighborhood-
level” biology, can further inform predictive models. Recent technological breakthroughs in highly multiplexed
imaging and spatial transcriptomics offer an unprecedented opportunity to delineate the therapeutic
consequences of spatial relationships within clinical tumor samples. Quantitative spatial features can provide
independent valuable information, which is unlikely to be captured by clinical, genetic and bulk-transcriptional
predictors. Hence, we propose to integrate highly multiplexed imaging data with omic approaches to delineate
mechanisms of resistance and build predictive models of response for patients with T-cell lymphoma, who
have a desperate unmet clinical need. In Aim 1 (K99 phase), I will build automated computational tools to
robustly quantify spatial features from highly multiplexed imaging data and integrate it with exome and RNA-
Seq. I will utilize >100 primary specimens collected pre-, on- and after-treatment with the PI3K-δγ inhibitor
duvelisib to nominate mechanisms of de novo and acquired resistance. In Aim 2 (K99 phase), I will build an
integrated machine-learning model to predict which patients are most likely to benefit from duvelisib and
evaluate the impact of spatial features towards model performance. In Aim 3 (R00 phase), I will validate the
model in an independent cohort and extend to samples from patients treated with additional agents, to identify
consistent and parsimonious signatures of spatial features that could be developed for broader use. My
extensive background in computational biology and experimental biology puts me in a unique position to
accomplish this proposal. During the K99 phase, I will be supported by an outstanding and interdisciplinary
team of advisors and collaborators (Drs. David Weinstock, Peter Sorger, Jon Aster, Allon Klein, Peter Park,
and Steven Horwitz) with expertise in all aspects of the proposed research. I will acquire new skills in (1)
computational analysis of highly multiplexed imaging to model molecular and spatial information, (2) data
integration methods to delineate regulatory programs for designing effective drug combinations and (3)
analysis of predictive biomarkers in clinical trial samples from clinical trials. Together with institutional support
from Dana Farber Cancer Center and formal coursework and training, I will bridge my knowledge gap in cancer
biology and gain the communication and leadership skills vital to transition into an independent position and
establish an independent, data science-driven, translational research program.

Public health relevance
PROJECT NARRATIVE T-cell lymphomas (TCLs) are highly diverse and patients with relapsed disease have a dismal prognosis. The PI3K-δγ inhibitor duvelisib induces response in 60% of patients with TCL through tumor cell-intrinsic and immunomodulatory mechanisms, but nearly all responders ultimately develop resistance. We hypothesize that the integration of spatial data, including neighborhood analyses to identify para- and juxtacrine interactions, with genetic and transcriptional alterations will inform predictive models for duvelisib response and nominate mechanisms of de novo and acquired resistance that can aid therapeutic selection and broadly applied across tumor types.